Elucidating the Role of Plasma Membrane V-ATPases in Breast Cancer Metastasis

? DESCRIPTION (provided by applicant): Metastasis, or the spread of a primary tumor to secondary sites in the body, is the leading cause of death from cancer and effective anti-metastatic therapies are not currently available. The vacuolar (H+)-ATPase (V- ATPase) is an ATP-dependent proton pump that transports protons across intracellular and plasma membranes. It plays an essential role in intracellular, pH-dependent processes, including protein trafficking and degradation, endocytosis, and zymogen activation. V-ATPases present on the plasma membrane of specialized cells also function in such processes as bone resorption and pH homeostasis. It was recently discovered that the V-ATPase is expressed on the plasma membrane of invasive breast cancer cells and that inhibition of V-ATPase activity prevents in vitro invasion of these cells. Targeting of V-ATPases to different cellular membranes is controlled by subunit a, which in mammals is expressed in four isoforms (a1-a4). We have demonstrated that loss of subunit a3 in invasive breast cancer cells reduces invasiveness and its overexpression in a noninvasive breast cell line enhances both invasiveness and plasma membrane V-ATPase expression. We have recently found that the activity of plasma membrane V-ATPases is critical for breast cancer cell invasion. However, it has not yet been directly tested whether these plasma membrane V-ATPases contain subunit a3 and the mechanism by which the V-ATPase contributes to invasiveness is unknown. Furthermore, the role of the V-ATPase in in vivo breast cancer metastasis has not yet been assessed. Aim 1 of this project will determine whether subunit a3 is present in V-ATPases at the plasma membrane of a3- overexpressing breast cancer cells. Aim 2 will determine the mechanism by which the V-ATPase contributes to breast cancer cell invasion. I will test the hypothesis that invasive breast cancer cells target th pump to the plasma membrane to promote the extracellular acidification required for the maturation and activity of acid- dependent proteases involved in metastasis. Aim 3 will assess the role of subunit a3 in breast cancer metastasis in vivo. The results of these studies are criticl to exploring a3-containing plasma membrane V- ATPases as a novel and effective target to block breast cancer metastasis in vivo and will enhance our knowledge of the breast cancer metastatic cascade.

Public health relevance
PUBLIC HEALTH RELEVANCE: Metastasis, or the spread of a primary tumor, is the leading cause of death from breast cancer and there are currently no available therapies that effectively target this process. The V-ATPase is an ATP-dependent proton pump that is expressed at the plasma membrane of invasive breast cancer cells and is involved in the in vitro invasiveness of these cells. The proposed study will examine the role of plasma membrane V-ATPases in in vitro and in vivo breast cancer cell metastasis and determine the mechanism by which the pump is involved in this process, thus providing insight into how this proton pump might be targeted to block the spread of breast cancer in humans.